Visual Science Training Program

Project Summary
In this renewal application, funding is requesed for continued support of the Johns Hopkins
University T32-supported Visual Sciences Training Program (VSTP) (2020-2025). The VSTP is
a combined effort of the Wilmer Eye Institute (Department of Ophthalmology) and the
Departments of Neuroscience, Molecular Biology and Genetics, Biology, and Institute of Genetic
Medicine. The program, administered and directed by PI Donald Zack and co-directors Jeremy
Nathans and Amer Riazuddin, provides a multidisciplinary training platform with a diverse
faculty covering cover many of the major avenues of modern visual science. The goal of the
program is to recruit young, talented scientists into the visual sciences, and to provide them with
broad theoretical and methodological research training, which will allow them to contribute to
our understanding of the biology of vision and the pathological mechanisms responsible for
visual loss in the context of human disease. Johns Hopkins is fortunate to have a large number
of investigators exploring different avenues of vision research; their approaches range from the
molecular and cellular to the systems levels, and the technologies they employ include cell
biology, molecular biology, biochemistry, developmental neurobiology, stem cell biology,
electrophysiology, functional imaging, psychophysics, bioinformatics, genomics, and genetics.
This diverse vision research community provides a wide variety of research options for VSTP
trainees. In this VSTP renewal application, we are proposing to accept two predoctoral students
per year and support both of them for two years, and to accept two postdoctoral fellows per
year, and to support each of them for one year. As part of our training program, the VSTP, in
collaboration with Wilmer Eye Institute and other Hopkins graduate programs, organizes and
provides vision-related courses, seminars, and related activities. Additional training in the
problems of clinical ophthalmology, with an emphasis on translational problem solving, is
available to all VSTP trainees through the medical student ophthalmology program and grand
rounds. Through these programs, we hope to continue and expand upon the VSTP’s success in
recruiting, inspiring, and training the next generation of vision scientists.

Public health relevance
Project Narrative The overall goal of the T32-supported Visual Sciences Training Program (VSTP) is to recruit talented young researchers, both pre- and postdoctoral fellows, and provide them with broad research training in the visual system, ranging from normal development and function to mechanisms of vision loss in the context of human disease. This training will prepare the trainees for careers in the visual sciences.